Statistical modeling to support population and translational cancer research

PROJECT SUMMARY/ABSTRACT
Developing effective strategies for cancer control requires rigorous analysis of empirical evidence and
similarly rigorous analysis to address inevitable gaps in empirical evidence. During the previous project
period, the Principal Investigator provided critical statistical support for a broad spectrum of research studies
focused on prostate cancer, ranging from basic science experiments through clinical trials and population
modeling studies. In this renewal application, he will continue to provide biostatistical analysis services for a
multi-project translational prostate cancer research program and computer modeling expertise for a cancer
surveillance research program that uses biomathematical models to address evidence gaps and inform
population prostate cancer policies. He will also serve as lead modeler in the Data Modeling and Analytics
Core of a new multi-project research program that will investigate clinical utility of novel cancer diagnostic
technologies and multi-cancer early detection tests. Successfully supporting these research programs
requires broad expertise in biostatistical methods, computer programming, and data analysis to identify and
implement appropriate methods, interrogate model assumptions, and bracket uncertainty in results.
Outstanding scientific collaboration and communication skills are essential to explain strengths and
limitations of selected approaches and to bring projects from the scientific inquiry phase through peer
review so that their results can impact the delivery of care. During the previous project period, the Principal
Investigator consistently demonstrated all these skills and has been instrumental in establishing his
research group's leadership in cancer modeling for evidence generation and policy development. Planned
studies for the renewal period include modeling of natural history and outcomes for new multi-cancer early
detection tests, investigating outcomes of strategies for precision early detection and treatment, and
identifying targeted screening and treatment strategies to reduce health disparities. Renewal of the Principal
Investigator's Research Specialist award will facilitate his research group's continued stellar level of
productivity and foster his continued dissemination of high-impact research characterized by statistical and
modeling approaches that are transparent, rigorous, and reliable.

Public health relevance
PROJECT NARRATIVE Revolutionary advances in cancer detection technologies promise to improve patients' lives, but timely evaluation is challenging. This project will support rigorous statistical modeling and analyses to close gaps in evidence for new and established cancer diagnostic tests, including developing sound screening and confirmation protocols, investigating precision treatments, and identifying pathways to narrow health disparities.